Hypertrophic adipocytes as biophysical mediators of breast cancer progression

PROJECT SUMMARY
Over 40% of adult women in the U.S. are obese and obesity will soon overtake smoking as the leading risk factor
for cancer. For breast cancer, obese women demonstrate both a higher incidence and higher rate of cancer-
related mortality compared to normal weight women. While many studies focus on potential systemic
connections behind this observation, the breast is rich in white adipose tissue (WAT), which is highly remodeled
in the context of obesity, and thus local tissue-resident cues must also be considered. At the cellular level, white
adipocytes are the functional units of WAT and secrete extracellular vesicles (EVs) that promote tumor
progression. Recent studies indicate that adipocyte-derived EVs contain lipids and other metabolites for fatty
acid oxidation that modulate tumor cell metabolism to increase migration, proliferation, and chemoresistance. In
obese individuals, adipocytes become hypertrophic with known consequences for metabolic disease. Whether
adipocyte hypertrophy similarly impacts breast cancer risk and prognosis is less clear. Preliminary data in this
proposal indicate that hypertrophic adipocytes promote the proliferation and migration of co-cultured tumor cells
to a greater extent than donor-matched, non-hypertrophic control adipocytes. Moreover, I found that hypertrophic
adipocytes secrete more EVs and exhibit remodeled cortical actin. Given that the actin cytoskeleton mediates
the biogenesis of EVs by other cell types, this proposal aims to investigate if hypertrophy, remodeled cortical
actin, and increased EV secretion are interconnected. Moreover, the proposed research also aims to discern if
these differences impact breast cancer progression by altering tumor cell metabolism. In Specific Aim 1, I will
characterize the concentration, size distribution, and cargo of EVs released by hypertrophic vs. control
adipocytes via nanoparticle tracking analysis and mass spectrometry. In Specific Aim 2, I will expose breast
cancer cells to EVs secreted by hypertrophic vs. control adipocytes to assess how treatment impacts tumor cell
behavior in vitro and in vivo. Moreover, I will perform pharmacological and genetic inhibitor studies to determine
if altered fatty acid oxidation underpins any observed differences in tumor cell phenotypes. Collectively, this work
will help discern if hypertrophic adipocytes constitute a distinct subpopulation of cells conducive to tumor
progression and thus contribute to the poor prognosis of obesity-associated breast cancer. In the clinic, identified
molecular mechanisms between adipocytes and tumor cells could be targeted therapeutically and the degree of
mammary adipocyte hypertrophy could serve as a prognostic biomarker for patient outcomes. Beyond research,
I will develop skills around experimental design, data analysis, mentorship, and science communication through
my training goals and team of mentors outlined in this proposal. These skills will be essential to achieve my long-
term professional goal of becoming an independent investigator at a research-focused institution.

Public health relevance
PROJECT NARRATIVE Breast cancer is the most common cancer in the United States and its incidence and mortality increase with obesity. This proposal aims to investigate if hypertrophic expansion of mammary adipocytes upon weight gain contributes to the poor prognosis of obese breast cancer patients via vesicle-mediated alterations to tumor cell metabolism. Collectively, this proposal will identify molecular mechanisms between adipocytes and tumor cells that can be targeted in the clinic and indicate if mammary adipocyte hypertrophy could serve as a prognostic biomarker for breast cancer patients.